Research Education Component

PROJECT SUMMARY - RESEARCH EDUCATION COMPONENT
The Northwestern ADRC, and the Mesulam Center within which it operates, have a solid tradition of mentoring
and training doctoral candidates, post-doctoral fellows and junior faculty in an interactive multidisciplinary
setting that provides research training through immersive activities and breadth of knowledge and skills
through a significant array of didactic educational modalities related to aging and AD/ADRD. During the past
cycle, the Research Education Component (REC) of the Northwestern ADRC has accrued much experience
and provided research education in aging and AD/ADRD to a large number of trainees. In the next cycle, the
overall goal of the Northwestern ADRC REC will be to optimize the training of a workforce to meet the nation’s
biomedical, behavioral and clinical needs in aging and AD/ADRD. The REC will have a broad mandate that will
interact with the activities of all other ADRC components and will be guided by the following goals:
1) Provide cross-disciplinary research education for three research associates and junior faculty per year
(REC Scholars) through innovative multidisciplinary mechanisms designed to bridge the gap between
clinical and basic research experience in aging and AD/ADRD, with a stipend to provide time for training.
2) Provide research education training for at least two REC Affiliates per year, similar to the training
provided to REC Scholars, but without a stipend.
3) Provide immersive research experiences and didactic training for at least five students per year at various
levels of education, with concentration on underrepresented minorities, as a means of enhancing the
pipeline for the future workforce in AD/ADRD.
In keeping with the overall theme of our ADRC, the REC program will emphasize the heterogeneity of brain
aging and dementia so that basic scientists are exposed to the complexity of the clinical presentations and
translate clinical findings into mechanistic studies, while clinicians appreciate the heterogeneity of the
underlying biological phenomena and translate basic findings into clinical research. The REC will be leveraged
by the extensive infrastructure of the Northwestern Clinical and Translational Sciences Institute (NUCATS),
with an extensive array of programs, including courses in Responsible Conduct of Research (RCR), and the
Northwestern University Graduate School, including the Northwestern University Interdepartmental
Neuroscience Program (NUIN), and the McGaw Medical Center of Northwestern Feinberg School of Medicine,
for diversity recruitment. REC will also organize the curriculum for didactic training modalities and will review
the background and career aspirations of trainees in order to ensure that clinicians become exposed to basic
research and basic researchers become exposed to clinical realities.